Immunomodulatory and behavioral effects of CAR T regulatory cell therapy for Alzheimer's Disease”.

Project Summary/Abstract:
Alzheimer’s disease (AD) is a progressive neurodegenerative disease that is one of the primary reasons for
memory dysfunction and dementia after 60 years of age. Neuronal dysfunction and death in the frontal cortex
and hippocampus, along with glia-mediated neuroinflammation and formation of aberrant protein aggregates
and fibrils are hallmarks of AD. Sporadic and familial forms of AD have an overproduction and/or decreased
clearance of extracellular amyloid-beta (Aβ) peptides and intraneuronal tangles of twisted tau protein fibers.
Neuroinflammation is known to occur in AD, and when associated near Aβ plaques there is a greater
neurodegeneration. Furthermore, peripheral immune activity and inflammation can affect inflammation in the
CNS. T regulatory cells (Tregs) are a subset of T cells that have inherent anti-inflammatory and
immunomodulatory properties. Tregs are found in the CNS under steady state conditions and increase trafficking
to regions of CNS inflammation. Less active or decreased numbers of Tregs has been found in AD patients and
depletion of Tregs can accelerate cognitive defects in murine AD models. We hypothesize that Tregs expressing
chimeric antigen receptors (CARs) with specificity to amyloid-beta (Aβ) will have immunomodulatory activity and
improve cognitive function of the 5xFAD B6 mice, a murine AD model. The aim of this proposal is to test the
innovative concept that Tregs engineered to express CARs against amyloid-beta will demonstrate
immunomodulatory effects in the CNS and in the peripheral tissues resulting in improved cognitive behavior. The
data generated will provide key proof-of-concept data to develop this novel therapeutic idea forward.

Public health relevance
Project Narrative Recent advances in cell therapy with autologous effector T cells engineered to target and destroy tumor cells is leading to extraordinary breakthroughs in cancer treatment. The current proposal seeks to develop new engineered T regulatory cells that modulate inflammation and improve cognitive function in Alzheimer’s Disease. Successful development of this innovative therapeutic strategy will be the foundation of new treatment approaches for patients.